Optimizing the Pulse Physiology Engine to Meet Medical Simulation Community Needs

1 Project Summary
2 The objective of our current R01 project, “Surgical Simulator for Improving Skill Proficiency and Resilience”, is
3 to design, develop, and validate methods by which simulation technologies can be used by practicing surgeons.
4 This project is extending the interactive Medical Simulation Toolkit (iMSTK) by developing software templates
5 for rare and adverse event simulation including physiological modeling, automating skill assessment, and
6 performance management in surgical simulations, which are critical for building powerful simulation applications
7 for practicing surgeons. Physiology remains an aspect of interactive real-time simulation that is rarely dealt with.
8 In most instances physiological models are developed separately without coordination with interactive surgical
9 simulation. In our current grant, we are integrating Kitware’s open source Pulse Physiology Engine with iMSTK
10 to build a closed-loop physiology model that handles local physiology changes and global, systemic physiological
11 responses. We are demonstrating these new developments by building a virtual surgical simulator for
12 cholecystectomy with bile duct injury and other rare complications that occur in this type of surgery. The goals
13 of our supplement are to 1) improve the computational efficiency of Pulse, 2) advance the external interfaces for
14 Pulse, including the Unity Asset, and 3) engage and promote Pulse to expand the user community. These goals
15 will support the parent grant by 1) improving computational efficiency to ensure that Pulse does not engage
16 critical computational resources required for graphical render, displacement and force calculations, and haptic
17 interface integration and 2) making Pulse more readily accessible via external interfaces, such as Unity, which
18 is the simulator environment for our parent grant. The supplement will also have a significant impact on medical
19 simulation in general by improving the accessibility of the Pulse via additional external interfaces, such as an
20 Unreal Plugin and interface language support, including Python, C#, and Java. We plan to engage the community
21 via publications, software releases, blog posts, and a workshop at a computational modeling conference. We
22 will engage Kitware’s well-respected software development team with the Key Personnel of the parent grant to
23 advance the Pulse platform and engage with our community of users.
24
25

Public health relevance
1 Project Narrative 2 3 Virtual simulators are powerful tools for training clinicians and surgeons across a wide range of 4 specialties and skill sets. The Pulse Physiology Engine is an open source platform that provides 5 accurate and consistent dynamic patient feedback via validated computational models. Our goal 6 is to grow Pulse’s community of users and increase the number of simulators using Pulse by 7 improving the computational efficiency, making Pulse more accessible to the medical modeling 8 and simulation community via external interfaces, and engaging our growing community of users 9 with blog posts, publications, software releases, and workshops. This supports both our current 10 R01 specifically and the medical training community in general.